Rapid Stress Response in Bacterial Pathogens: the Role of Extant Porins in Antibiotic Tolerance

Project Summary
Cells of most Gram-negative bacterial pathogens can develop tolerance to chemical stressors through rapid
adaptations in the outer membrane that are poorly understood. This application focuses on uncovering the
adaptation mechanisms responsible for stress-induced tolerance to chemical stressors, such as antibiotics, in
major pathogenic bacterial species. A first-line defense in Gram-negative species is inhibiting porin-mediated
uptake to minimize stressor accumulation within the cell. By preventing or delaying the intracellular buildup of
bactericidal compounds, the cell may gain sufficient time to activate stress response pathways. The prevailing
view suggests that phenotypically tolerant bacteria survive by inhibiting porin function through the downregulation
of their synthesis. However, a critical gap exists in the current understanding of porin-mediated phenotypic
tolerance: even if the expression of porins is downregulated, there are currently no known ways to eliminate
existing porins in the outer membrane. Theoretically, the cell must divide multiple times under stressful conditions
to gradually decrease porin abundance. This scenario is improbable because the stressful conditions might
hinder cell division, or the cell could perish before dividing. New evidence from the PI's lab suggests that E. coli
can adaptively restrict intracellular accumulation of drugs by inhibiting the functioning of extant porins within
minutes of exposure to stress. The proposed work will test the central hypothesis that cells attempt to block mass
transfer through their porins within seconds or minutes of exposure to a chemical stressor, with the purpose of
limiting its intracellular accumulation. A combination of single-cell growth and CFU (colony-forming units) assays,
fluorescent dye-uptake (fluorescence), and motility assays will be performed to probe physiological responses
of cells under micro-confinement during stress. The experiments will be compared with mathematical models of
drug transport to explain how heterogeneity in phenotypic tolerance mechanisms emerges in sensitive
populations. In particular, the proposed work will explain how energetically active cells develop antibiotic
tolerance while preserving ATP and the proton-motive force (PMF). The proposed work will define novel
mechanisms of stress tolerance in pathogens, with wide implications for antibacterial therapies and human
health.

Public health relevance
Narrative Bacterial pathogens often develop multidrug tolerance that can lead to clinical recurrence of infections. Tolerance is challenging to study owing to the high degree of heterogeneity in stress tolerance mechanisms. In this work, innovative biophysical approaches will be used to explain diverse adaptation mechanisms in phenotypic tolerance, which is expected to help combat antibiotic resistance.